Integrative modelling of single-cell data to elucidate the genetic architecture of complex disease

PROJECT SUMMARY/ABSTRACT
Leveraging Genome Wide Association Studies (GWAS) to understand disease has proven challenging, as the
underlying biological mechanisms are often poorly captured by bulk tissues. Recent advances in single-cell
sequencing have led to a torrent of data across multiple modalities, contexts, and individuals, which provide an
unprecedented opportunity to understand disease biology at high resolution. We hypothesize that the fine-scale
cellular contexts captured by single-cell data will be effective at explaining disease heritability and fine-mapping
disease mechanisms. However, current approaches to integrate single-cell data with GWAS largely rely on off-
the-shelf approaches developed for bulk sequencing, which obscure the rich phenotypic diversity present in
individual cells within and across canonical cell types. The sparse and highly variable nature of single-cell data
has additionally posed challenges for robustly identifying single-cell quantitative trait loci (QTL). Single-cell data
continues to increase in size and complexity, emphasizing the need for scalable integrative modeling. Here, we
propose a 5 year research plan to develop novel approaches for integrating single-cell data with GWAS by
modeling complex cellular phenotypes not captured by existing bulk approaches. Our proposal will identify novel
disease-relevant cell states; leverage multiple single-cell modalities to fine-map disease variants and their target
genes; and discover novel single-cell QTLs associated with disease. Our specific aims are: Aim 1: Leveraging
single-cell epigenetic data to identify heritable components of disease; Aim 2: Leveraging single-cell data to fine-
map disease variants and their mechanisms; Aim 3: Defining the regulatory effects of disease variants using
population-scale scRNA-seq. While our proposed approaches are broadly applicable to common diseases, we
will benchmark them on immune-related traits and neuropsychiatric traits which we have studied extensively with
bulk datasets in published work and where we have now aggregated a large collection of relevant single-cell
datasets. Our collaboration has multiple strengths: our focus on functional data integration across multiple single-
cell modalities; our broad statistical and computational expertise; and our extensive, data-driven publication
record on common disease.

Public health relevance
PROJECT NARRATIVE Genome-Wide Association Studies (GWAS) have identified thousands of common, non-coding variants associated with disease. While integration of GWAS data with gene expression from bulk tissues has uncovered some of the underlying genes and mechanisms, only a fraction of trait heritability can be explained by existing bulk datasets and the majority of GWAS loci do not colocalize with QTLs from bulk expression data. Understanding which cell types and contexts are the most relevant for a given disease – both at the level of individual loci and across the genome – is thus critical to moving from individual variants to an understanding of broader processes and, eventually, to effective interventions.